Role of Hofbauer cells in prenatal inflammation at the maternal-fetal interface

PROJECT SUMMARY/ABSTRACT
Prenatal inflammation is observed in pregnancy complications, especially those complicated with preterm birth
(PTB). Prenatal inflammation is a major cause of neonatal mortality and morbidity with significant impacts on
neurodevelopment as well as lung and immune system development. PTB affects 10-12% of births in the United
States. The cellular process behind the subsequent altered placental inflammation is not fully understood,
complicating attempts to treat or prevent it. Thus, the objective of this grant is to investigate the mechanisms
through which placental resident macrophages, namely Hofbauer cells, are involved in the placental
impact of prenatal inflammation. Hofbauer cells are the predominant immune cell type within the placenta;
these macrophages are known to release pro-inflammatory cytokines when stimulated. The central hypothesis
that the pro-inflammatory profile at the maternal-fetal interface with prenatal inflammation is primarily
driven by Hofbauer cells will be addressed in two specific aims. First, the Hofbauer cell inflammatory profile
in physiological birth (Term) vs. pathological pregnancies (PTB) will be determined. Second, the Hofbauer cell-
specific contribution to the altered inflammatory profile, as is observed in the placenta following pathological
prenatal inflammation, will be modeled in in vitro and in vivo models using pathogen-associated molecular
patterns (PAMP) stimulation. This project recognizes the complex dynamics of contribution to inflammation and
considers all cell types, and their spatial distribution, within the placenta in inflammatory contribution. Thus,
spatially resolved techniques will be used to study the Hofbauer cell contribution to inflammation. Our models
include primary cell suspensions combined with a rodent model. Ultimately, this work will contribute to improved
understanding of the impact of prenatal inflammation at the maternal-fetal interface, the role of Hofbauer cells in
response, and potential for targeted anti-inflammatory therapy. Completing the planned education outlined in
goals for fellowship training and this project will contribute to my overall formation as an independent physician
scientist with a career in advancing the research and care for women’s health.

Public health relevance
PROJECT NARRATIVE Prenatal exposure to uncontrolled inflammation can cause devastating effects on the placenta, and subsequently the neonate, and remain incompletely understood. This proposal aims to understand the role of placental fetal resident macrophages (known as Hofbauer cells) in the context of prenatal inflammation (including pathological inflammation leading to preterm birth) or physiological birth. This study will provide a better understanding of the Hofbauer cell-driven mechanism of prenatal inflammation as well as identify novel targeted therapeutics for prenatal inflammation.